Development of an early tooth organoid via human induced pluripotent stem cells

Project Summary/Abstract
Genetic and environment-mediated diseases that affect tooth formation and function can severely compromise
quality of life. While mouse models have significantly advanced knowledge of underlying biological processes
and genetic drivers, new tractable in vitro systems coupled with gene editing can provide enticing alternatives
for tooth bioengineering and disease modeling. Human induced pluripotent stem cells (iPSCs) are such a system
since they can in theory differentiate into any somatic cell type, including major dental cell lineages such as
odontoblasts and ameloblasts. To this end, the methodology of directed differentiation is used, which is a
multistage process with recapitulation of developmental milestones to derive clinically-relevant cell types from
iPSCs. Robust, efficient, and reproducible derivation of the earliest dental multipotent progenitors is key for the
successful implementation of iPSCs in dental medicine but there exists an incomplete understanding and
suboptimal recapitulation in vitro of early tooth development. To address this critical gap, an integrated approach
is presented consisting of a logical sequence of experiments that combine human iPSC-based tooth organoid
studies with high resolution in vivo studies of early tooth development.
First, human iPSC reporter lines for transcription factors that are highly enriched in and define to a great extent
the earliest mesenchymal and epithelial progenitors that originate from cranial neural crest and oral ectoderm,
respectively, will be generated and used. As the derivation of dental cell types from human iPSCs through the
methodology of directed differentiation depends heavily on prior developmental knowledge, the current
application proposes the mapping of the earliest dental progenitor populations (both mesenchymal and epithelial)
through single-cell RNA-Seq/ATAC-Seq to define genome-wide gene expression and profile regions of open
(nucleosome-free) chromatin, respectively. These studies will be complemented with spatial transcriptomics at
the same time points of tooth development that will define at exquisite detail the spatial relationships of the
emerging dental epithelium and mesenchyme. This knowledge along with information gleaned from the tooth
developmental literature, such as signaling pathways, will be used to derive their in vitro human counterparts
with high efficiency and fidelity; the latter will be quantified by using state-of-the-art cell similarity methods. The
proposed studies will provide new insights in early tooth development and set the basis for a robust human iPSC-
based tooth organogenesis system to be used in precision dentistry, including future dental tissue replacement
strategies.

Public health relevance
Project Narrative This proposal aims to derive the earliest dental progenitors, i.e. the cells that can develop to form a whole, functional tooth, from human induced pluripotent stem cells (iPSCs). The robust derivation of such progenitors with robust odontogenic (dentin and enamel) potential will set the foundation for the establishment of an iPSC- derived human tooth germ to be used for research/clinical ends. Applications range from development of in vitro models of tooth development, to “disease-in-a-dish” modeling of and development of therapies for congenital dental defects.